GO MOMS hybrid simulation model for labor and delivery care

Project summary With the increasing maternal mortality in the USA, modalities to reverse this trend is an imperative. Improvement in knowledge for individual health care workers and enhancement of team performance, especially communication, has been clearly identified as a gap in providing quality care. Simulation-based training as an educational tool is a proven entity for team performance and communication; however, widespread dissemination of simulation technique is hampered by the present model of on-site training by specialists. This project will evaluate the effectiveness of a hybrid simulation program - combining online training (telesimulation) with a shortened in- person training in lower resource hospitals. If successful, simulation-based training will be more accessible to hospitals that have a high burden of populations that are affected disproportionately by maternal morbidity and mortality, such as those with higher underserved minority and socio- economically challenged populations and rural communities.

Public health relevance
Project Narrative Maternal mortality and severe morbidity during childbirth in the United States is a major public health concern. Simulation methodology has been used to educate healthcare professionals to care better for conditions such as postpartum hemorrhage, hypertensive disorders of pregnancy, and maternal cardiac arrest. We aim to distribute simulation training methods using a hybrid remote and on-site approach to hospitals that are generally under-resourced and serving disproportionately affected populations.